Dynamic Internal Spatial Organization of Mitochondria

Project Summary
Mitochondria are double membrane-bound organelles that perform many crucial cellular functions, including
nucleotide and amino acid metabolism, cellular Ca2+ homeostasis, and their most well-known function,
generation of cellular energy via oxidative phosphorylation. To perform these diverse functions, the
mitochondrial interior is elaborately physically organized. Mitochondria are also distributed throughout cells as
part of a dynamic, semi-continuous network that divides and fuses in part to distribute the mitochondrial
genome. Correct mitochondrial organization and distribution are critical for cellular function, and defects in
processes that maintain mitochondrial architecture can result in a large number of diseases, including
neurodegeneration and diabetes. Despite the complicated nature of mitochondrial structure, we have a minimal
mechanistic understanding of how cellular metabolic needs are communicated to the interior of the organelle
and how mitochondrial organization is dynamically modulated to meet this demand. In the next project period,
our goal is to address this deficit by studying three distinct aspects of mitochondrial communication and
internal remodeling. We will examine how mitochondrial structure is coordinated across the two mitochondrial
membranes during mitochondrial fission (Direction 1), how mitochondria internal organization is remodeled to
support local subcellular metabolic demand (Direction 2), and how the interior of the organelle can sense and
respond to acute localized stress and communicate this dysfunction to external quality control machinery
(Direction 3). This work will lead to insight into the spatial organization and form-function relationship of
mitochondria and give us molecular understanding of the disorganization and dysfunction of mitochondrial
membranes that frequently occurs in human disease.

Public health relevance
Project Narrative Mitochondria are double membrane-bound organelles that perform many cellular functions, including the generation of energy via respiration. Mitochondrial function depends on the maintenance of proper internal organization and defects manifest in a wide range of diseases including diabetes and neurodegeneration. The proposed work will determine mechanisms by which the mitochondrial interior dynamically reorganizes to maintain organelle integrity, remodels to meet subcellular metabolic needs, and senses and responds to acute stress, with the long-term goal of identifying therapeutic approaches to alleviate diseases with underlying mitochondrial dysfunction.